Renovation of Core Laboratories for the DC Intellectual and Developmental Disabilities Research Center

Project Summary Children’s National Hospital (CNH) proposes to relocate 15,520 GSF of advanced core facility research space in support of its NIH funded District of Columbia Intellectual and Developmental Disabilities Research Center (DC- IDDRC). The relocation and expansion of this program will be from CNH Sheikh Zayed campus to the new Children’s National Research and Innovation Campus located at the former Walter Reed Army Medical Center site in Northwest Washington, D.C., 4 miles from the hospital. The project involves renovation/modernization of one floor of the former Armed Forces Institute of Pathology building originally constructed in 1955. The total cost of this construction is estimated to be $9,446,951. This CO6 requests a budget of $8,000,000 with the remainder of the cost (approximately $1,446,951) being funded by CNH. This state-of-the-art core facility will allow the conduct and expansion of genetic and neuroscience research initiatives of the DC-IDDRC, an interdisciplinary and inter-institutional research center. The mission of this IDDRC is to improve the understanding and treatment of children with developmental disabilities, including autism, cerebral palsy, epilepsy, inherited metabolic disorders and intellectual disability. The new space will support 3 cores that will be accessible to investigators from the four institutions that comprise the DC-IDDRC: CNH, George Washington University (GW), Georgetown University and Howard University. The construction will also include shared hoteling laboratory space for DC-IDDRC investigators whose laboratories are not on- site but who are utilizing the core facility. The proposed DC-IDDRC cores consist of: 1) Cell and Tissue Microscopy, 2) Genomics and Bioinformatics, and 3) Induced Pluripotent Stem Cells (IPSC).